Tracking and Prediction of Early Brain-Face Biomarkers of Prenatal Alcohol Exposure from Neonates to Children

Maternal substance use disorders are a substantial public health concern and the neurological
consequences of prenatal exposure are a major threat to the long-term health of offspring. Globally,
prevalence of Fetal Alcohol Syndrome (FAS) and Fetal Alcohol Spectrum Disorders (FASD) is between 2-7
and 20-50 per 1000, respectively. By contrast, in certain high-risk communities in South Africa, prevalence
is reported to be as high as 63 and 155 per 1000, respectively. Though prenatal alcohol exposure (PAE) is
known to affect the central nervous system, to date, little data exists in respect of the impact of PAE in early
childhood, before both higher-level brain networks are established and other potentially confounding post-
natal environmental influences have come into play. For neurodevelopmental disorders, studies have
consistently shown that early intervention, based on detection and targeted interventions, leads to better
long-term outcomes. We aim to address this precise gap in knowledge by imaging the brain and 3D
face across the FASD continuum to investigate early biomarkers, trajectories and functional
correlates of PAE in a cohort followed prospectively from birth to age 6 years. Data: Our cohort
includes a well characterized subsample of children (PAE and healthy controls) enrolled in the Drakenstein
Child Health Study in Cape Town, South Africa, who have been scanned as neonates and at 2-3 years of
age. Preliminary published data shows highly significant relationships between PAE and regional gray and
white matter changes, already discernible in newborns, well before the age FASD is typically diagnosed. An
additional longitudinal assessment at 6-years will yield a unique FASD sample with 3 distinct time points
(infants, toddlers and children), allowing characterization of brain and face morphology and brain structure
and function in this previously understudied early developmental period. This proposal addresses
fundamental gaps concerning the presence, timing and regional specificity of altered brain morphology and
structural and functional connectivity in association with the effects of PAE on the developing brain from
birth to 6 years, and the relationships with facial dysmorphology. The research team has successfully
gathered data from the proposed cohort as neonates and at 2–3 years of age. The benefits of extending
this research to a subsequent imaging time-point, with a larger range of developmental and
neurobehavioral assessments, provides an unprecedented opportunity to determine longitudinal effects of
PAE on the trajectory of the developing brain in these critical early years, the links between neural and face
predictors of PAE and the long-term clinical significance of these findings. This research will illuminate early
neurodevelopmental mechanisms leading to subsequent behavioral and neurological disturbances, which
may allow opportunities for targeting interventions when brain plasticity is still relatively fluid. This project
might also lead to new strategies for early diagnosis using both face and brain biomarkers.

Public health relevance
Project Narrative Fetal exposure of the brain to alcohol can trigger brain abnormalities that unfold over a lifetime with severe consequences both for the affected individual and for society at large. To date, these brain abnormalities and associated deficits and behaviors have mostly been studied in late childhood or later, with very few studies following the consequences of well documented fetal alcohol exposure as they develop in the same individual across time in early childhood when the brain is most responsive to potential treatments. This project will extend an ongoing study of children with fetal alcohol exposure, already characterized as newborns and at age 2-3 to add assessments of the brain and behavior at age 6 and will explore alcohol-induced facial abnormalities as a complementary predictor of brain problems. !